Metagenomic Profiling of Dust Samples for School-based Viral Surveillance

PROJECT SUMMARY/ABSTRACT:
Respiratory viral infections are associated with significant morbidity in both children and adults. While genomic
sequencing of wastewater samples has emerged as promising means of monitoring emerging viral strains,
school-based sampling remains largely unexplored. The main objective of this proposal is to validate usage of
viral sequencing of dust from elementary schools for early detection of emerging viral strains. The central
hypothesis for this study is that viral metagenomic sequencing of dust samples obtained from elementary
schools can be used for viral surveillance and identify key viral strains that can affect key clinical outcomes
such as school absenteeism. The rationale for this project is that high viral diversity exists in elementary
schools, and school-based environmental sampling can be more sensitive than clinical sampling at detecting
viral strains. The central hypothesis will be tested through two specific aims: 1) evaluate early detection of
emerging viral genomes using viral metagenomic sequencing of classroom dust samples; and 2) identify viral
strains that best predict school absenteeism. To achieve these aims, an ancillary study will be designed based
on the School Inner City Asthma Intervention Study (SICAS-2: ClinicalTrials.gov NCT02291302) using 571
dust samples longitudinally collected from 209 classrooms across 41 schools from 2015-2019. Dust samples
will undergo viral metagenomic sequencing using a hybrid-capture approach. Under Aim 1, phylogenetic and
time-based analyses will be used to compare viral genomes from school dust samples to clinical genomes in
existing national databases. For Aim 2, predictive models using machine learning will determine the likelihood
of increased absenteeism based on the presence of specific viral strains. This project uses an innovative
sequencing approach to explore school environmental sampling for viral surveillance, offering critical insights
to advance targeted public health interventions and reduce exposures. The long-term goal of the candidate is
to develop expertise in virome sequencing in order to study the impact of environmental exposures on pediatric
respiratory health. To accomplish this, the training plan will be focused on building skills in bioinformatics,
machine learning, advanced biostatistics, and scientific and grant writing. This will be accomplished through
formal coursework, collaborative work, conference participation, and mentorship from experts in the field,
paving the way for a career development application and ultimately, an independent scientific career.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because it focuses on developing an innovative approach for precise viral surveillance through use of viral metagenomic sequencing of school dust. This study will offer novel insights into genome-based environmental sampling as a viral surveillance tool and will rank order key viral strains for targeted public health interventions. This study supports the NIH’s mission to reduce illness and disability by developing innovative methods for environmental monitoring to reduce viral exposures in schools and improve children’s health.